AZATHIOPRINE LOADING TO DECREASE RESPONSE TIME IN CROHN'S DISEASE

The purpose of the study is to compare Azathioprine IV loading dose with placebo IV loading dose for induction of remission (defined as a CDAI score <15) and total steroid withdrawal by 8 weeks in active Crohn's disease.